Mechanisms and manipulation of force dependent behavior in T cell biology

Summary
TCR recognition of peptides bound and presented by MHC proteins underlies cellular immunity. TCR recognition
of pMHC is most often viewed through the lens of traditional receptor-ligand theory, where cellular responses
are presumed to be governed by solution binding affinities or kinetics. While this is often the case, work over the
past several years has shown that complexities from mechanical forces exerted on membrane bound TCR and
pMHC can profoundly influence T cell signaling. Of notable interest are catch bonds: force dependent
enhancements of the lifetimes of TCR-pMHC complexes formed between interacting cells. Catch bonds can lead
to large changes in signaling output and can greatly enhance T cell sensitivity. Demonstrating the importance of
mechanical forces in tuning T cell responses, ligands that are recognized with strong affinity but fail to result in
catch bonds yield altered or even no T cell signaling. Force-dependent behavior has been implicated in a wide
range of T cell biological processes, including thymic education, responses to viral or tumor antigens, and viral
escape. Although the importance of mechanical force in TCR recognition has been demonstrated, we have only
a rudimentary understanding of how TCRs form catch or revert to slip bonds. We (PI Evavold) have had recent
success in manipulating TCR catch bonds (published in Science this year) but this was achieved through
screening libraries and without an understanding of mechanism. We thus lack predictive models for force
dependent behavior in TCRs and in turn how this affects biology, which in turn impacts our ability to predict
immunogenicity, assess the consequences of mutations, and hinders our ability to understand T cell specificity.
Recently, however, we developed a comprehensive framework to identify, manipulate, and predict force
dependent behavior in TCR-pMHC interactions. Unlike prior efforts, our framework directly addresses
mechanism. Here, we will further develop, refine, and apply our framework. Our driving hypothesis is that viewing
force dependent behavior through the lens of energy will provide the missing mechanistic detail of how and why
catch bonds emerge in TCRs, allow their rational prediction and manipulation, and permit force considerations
to be included in assessments of T cell recognition of antigen. Our three Aims are to 1) further develop our
mechanistic framework for force dependent TCR behavior; 2) explain how changes to catch bonds emerge from
natural variations in TCR interfaces and how catch bonds regulate T cell biology; and 3) Use rational catch bond
engineering to better control viral infection in mice. Overall, the work in this proposal will illuminate the opaque
mechanisms that underlie T cell mechanobiology, place catch bonds on a formal mechanistic footing, and
provide the means to predict and productively manipulate TCR catch bonds and ultimately T cell biology.

Public health relevance
Project narrative Mechanobiology has emerged as a new frontier in T cell biology. However, the mechanisms are poorly understood, which impact our collective ability to understand, predict, and control T cell immune recognition. Here, the mechanisms of T cell mechanobiology will be elucidated and used to better understand and control T cell recognition, with wide implications for understanding and manipulating the immune system in health and disease.